Development and Testing of Health Equity Measures in Home Health Care for Medicare Beneficiaries

PROJECT SUMMARY
Home health care is an essential healthcare service and benefit under the Medicare insurance programs,
aimed to improve health outcomes, reduce avoidable hospitalizations, and decrease institutional placements.
Racial and ethnic minority Medicare beneficiaries utilize home health care at higher-rates compared to the
general Medicare population. Despite the growth and increased use of home health in recent years, there is
little evidence about the role of home health agency organizational structures in home health quality and
equity. There is also a gap in knowledge about minority-serving home health agencies. Most “high-minority”
agencies are rated as lower quality by CMS; however, they may also provide culturally and linguistically
appropriate care that should be associated with the best outcomes and highest quality of care. This paradox
will be explored using a strengths-based approach, to understand factors associated with high-quality home
health care outcomes for racial- and ethnic minority patients overall, and within the context of minority-serving
home health agencies. The overall objective of the proposed project is to create home health process and
outcome equity measures by calculating race- and ethnicity-specific quality ratings to examine the
organizational characteristics of home health agencies with the highest ratings and those with the highest
share of patients of color. The evidence generated from this project will be an important first step in (1) creating
better measures of health equity that center marginalized populations, and (2) designing and evaluating health
systems and policy interventions with the goal of eliminating inequities in essential home health services.
Informed by Donabedian’s Structure-Process-Outcomes framework, race- and ethnicity-specific home health
quality ratings will be calculated for the process of care and outcome measures used in the Centers for
Medicare and Medicaid Services (CMS) star ratings. This study will match, merge, and link national Medicare
beneficiaries’ administrative, home health care assessment, and inpatient claims data with home health
agency level CMS Care Compare data to evaluate within-home health agency racial inequities in care quality
outcomes through two aims: (1) Compose and demonstrate the utility of race and ethnic group-specific home
health agency quality ratings, adapting the methodology used by CMS Care Compare. We will evaluate utility
of the new race- and ethnicity-specific measures in comparison to the original, overall measures through the
calculation of reliability and informativeness metrics. (2) Assess home health agency structure as a predictor of
quality and equity in home health agency process and outcomes. Home health agency structural factors (e.g.,
minority-serving, size, tenure, ownership, rurality) will be used to predict race- and ethnicity-specific care
quality process (i.e., timely initiation of care) and outcome measures (e.g., functional improvements,
hospitalizations). This work is both timely and significant, with the potential to profoundly impact quality and
health equity measurement within home health and other healthcare sectors.

Public health relevance
NARRATIVE This project will calculate and evaluate home health quality measures by race and ethnicity and home health agency characteristics. The evidence produced by this project will inform future intervention research and scalable programs that will better equip home healthcare agencies, clinicians, health systems, insurers, and policymakers to serve marginalized patient populations and advance health equity.